A Model for Homeostatic Plasticity in Striatum

PROJECT SUMMARY
Changes in synaptic weights encode new learning and the execution of learned behaviors. Such
changes occur across different timescales, all within dynamic systems that recalibrate and
compensate homeostatically to stabilize network activity and maintain activity within a useful dynamic
range. Strong data support that these stabilizing mechanisms are conserved evolutionarily and
represented across neural systems. In animal models, they have been best studied in sensory
systems and at the neuromuscular junction. Despite broad acceptance of these mechanisms, the
homeostatically stabilizing actions of most networks have not been documented and/or are poorly
understood. A normal functioning synapse can be strengthened or weakened over fast timescales
(seconds to minutes) and includes Hebbian forms of synapse plasticity such as LTP or LTD. In
cortical synapses forming on striatal projection neurons (SPNs), abnormal Hebbian synaptic plasticity
is a hallmark of anxiety- and addiction-like states and neurological disease models associated with
cognitive impairment or dementia. Collectively, the data indicate that Hebbian plasticity is vulnerable
to a variety of pathological conditions. However, the data also suggest that under such conditions,
corticostriatal networks are no longer kept within a useful working range—that the adaptive actions
designed to stabilize this largely closed-loop system may also be particularly vulnerable. Importantly,
whether or how corticostriatal circuits adapt to sustained increases or decreases in activity is not
clear, a significant lapse in understanding overall corticostriatal network function in health and
disease states. The specific goals of this multi-PI R21 are to define the nature of homeostatic
adaptation within SPNs. We will assess responses to widespread, targeted, and cell autonomous
increases or decreases in neural activity in vitro and within an intact system. These data will permit us
to build a testable model that can be used in the future for assessing how homeostatic mechanisms
become maladaptive or subverted by disease-related pathologies.

Public health relevance
PROJECT NARRATIVE A wide variety of neurological diseases and psychiatric systems arise from dysfunctional signaling in striatal circuits. Cellular and molecular studies suggest that deficits in mechanisms that serve to balance and stabilize signaling within these networks may be defective, but the rules governing such mechanisms within this region are poorly understood. To address this gap, the goal of the proposed research is to identify the dominant mechanisms driving adaptation in identified striatal circuits in vivo.